Scientific Information Management and Literature-Based Evaluations for the DTT - Support for Report Preparation

A number of complex scientific reports are prepared under this project by compiling information from Division of Translational Toxicology (DTT) staff, contract laboratory reports, and DTT data tables. Information is compiled, reviewed for internal and external consistency, and for scientific accuracy. Reports prepared under this project included Technical Reports on sulfolane, black cohosh, and triclosan; Toxicity Reports on phenolic benzotriazoles and Stachybotrys chartarum; and a NIEHS Report on nicotine bitartrate dihydrate. Keywords: report preparation, toxicology.